Elucidating the Molecular Underpinnings of Endogenous RPE Regeneration

SUMMARY: Diseases resulting in degeneration of the retinal pigment epithelium (RPE) are among the leading
causes of blindness worldwide, and no therapies exist that can replace RPE or restore lost vision. Age-related
macular degeneration (AMD) is one such disease, and is the third leading cause of blindness in the world.
Transplantation of stem-cell derived RPE has emerged as a possibility for treating AMD and clinical trials are
underway. An intriguing alternative approach to treat RPE disease is to develop therapies focused on
stimulating endogenous RPE regeneration. Indeed, strategies targeting endogenous retinal regeneration are
gaining traction as potential therapeutic approaches to treat a number of retinal degenerations. For this to
become possible for the RPE, we must first gain a deeper understanding of the molecular and cell biological
mechanisms underlying RPE regeneration. In mammals, RPE regeneration is extremely limited; small lesions
can be repaired by the expansion of adjacent RPE cells, but remaining RPE are unable to functionally replace
lost cells when the lesions are large. In some injury paradigms, RPE cells proliferate but do not regenerate a
morphologically normal monolayer. Moreover, RPE cells often overproliferate after injury, such as during
proliferative vitreoretinopathy, where proliferative RPE cells invade the subretinal space and lead to blindness.
A subpopulation of quiescent human RPE stem cells has been identified which can be induced to proliferate in
vitro and differentiate into RPE or mesenchymal cell types. This discovery is exciting because it suggests that
the human RPE contains a population of cells that could be induced to regenerate.
Despite these studies, little is known about the process by which RPE cells respond to injury to elicit a
regenerative, rather than pathological, response. There are also few models in which to study intrinsic RPE
regeneration. This knowledge gap is a major barrier to developing effective strategies to restore RPE lost to
disease or injury. To overcome this barrier, we developed a unique transgenic zebrafish model to study RPE
injury and regeneration and leveraged this model to begin to identify the molecular and cellular mechanisms
facilitating RPE regeneration. Our work to date supports our central hypothesis that injury-adjacent RPE cells
proliferate in response to RPE damage to generate RPE daughter cells that then regenerate RPE lost to injury.
Experiments in this proposal further test this hypothesis by i) determining how RPE heterogeneity influences
RPE regeneration and identify the source of regenerated RPE; ii) determining the cell biological mechanisms
underlying RPE regeneration; and iii) determining how the nrg1/ErbB pathway facilitates RPE regeneration.
Understanding how injury-responsive RPE cells proliferate in vivo and the signals/pathways active during the
injury response holds significant promise to identify strategies to stimulate or reactivate this ability in the human
eye, which would be transformational for treating AMD and other diseases that affect the RPE.

Public health relevance
PROJECT NARRATIVE: Diseases resulting in degeneration of the retinal pigment epithelium (RPE) are among the leading causes of blindness worldwide and no therapy exists that can replace RPE or restore lost vision. An intriguing approach to treating RPE diseases is to develop therapies focused on stimulating endogenous RPE regeneration. Experiments in this proposal utilize a zebraﬁsh model of RPE regeneration to identify the molecular and cell biological underpinnings of this process.